Administrative Core

The purpose of this core is to provide administrative support to all of the projects and cores. Under the supervision of the program director, this core will perform all activities related to day-to-day management of the grant. These include budgetary control, organization of retreats, meeting and conference scheduling. It will be responsible for facilitating and coordinating program-wide functions that increase interactions of the various projects and investigators, and with the external and internal advisory boards. This core is the means by which the program director carries out this function. It supports all of the cores and projects equally.